RESEARCH CAPACITY CORE

PROJECT SUMMARY
RESEARCH CAPACITY CORE
Prostate cancer is the most common cancer type found in senior men and a second leading
cause of cancer deaths among American men. Although prostate cancer grows slowly, the major
cause of prostate cancer death results from cancer metastasis and chemoresistance. In
African­American men, the incidence of prostate cancer is 65% higher and the mortality rate is
more than double compared to Caucasian men. The cause for this racial disparity in both
incidence and death rate in African­Americans are ill­defined, but considerable evidence points
to roles for an array of biological and environmental factors. The Center for Cancer Research and
Therapeutic Development (CCRTD) at Clark Atlanta University (CAU) is committed to an ongoing
mission which is to advance our understanding of and ability to alter the pathogenesis and risk
factors associated with prostate cancer and its associated disparities through three research
projects and fifteen pilot projects in this renewed proposal. The Research Capacity Core at CAU
proposes to continue supporting rigorous, reproducible research in three ways: 1) Support
research projects by maintaining the core laboratories, core laboratory personnel and services
that will be utilized by the project leaders and other users of the core; 2) Provide training to ensure
that project leaders and other users are acquainted with the use of core equipment; and 3)
Enhance biomedical research capacity to allow projects leaders and other users of the core to
develop their research projects toward pre­clinical and/or clinical research.